Research Cores

Research Core Summary/Abstract
The ND INBRE consulted the network to determine the best mechanism to build the research
base and increase capacity for faculty, postdoctoral fellows, graduate students, and
undergraduate students. Stakeholders identified that enhanced capacity could be best
achieved by modernizing the research base. The stakeholders identified flow cytometry and
cell sorting, confocal microscopy and microdissection, and animal behavior as facilities that
would increase investigator capacity while building the research base. These technologies are
required to be located close to the research base, since samples are difficult to send to
commercial suppliers. This technology also has limited availability in ND and is not available at
the PUIs or TCUs. The facilities are accessible to all investigators in ND and the PI of the ND
INBRE provides his own laboratory space as needed so outside users can analyze their
specimens. The facilities also have dual use for research and teaching, as noted by their use in
workshops for students from the PUIs and TCUs. The environmental core was formed by
request from the investigators at the PUIs and TCUs who examine metals in a wide variety of
environmental samples. The INBRE programs are encouraged to collaborate with other IDeA
programs, such as COBREs, CTR, and commercialization HUBs. The ND INBRE and its academic
base, the Department of Pathology, have provided over $3,500,000 over the last 5 years to
strengthen our network partners.